ASU Roybal Administrative Core

Abstract (The Administrative Core)
Living alone has become increasingly common over the past few decades among older adults, including
those with cognitive decline (defined as subjective cognitive decline [SCD], mild cognitive decline [MCI], or
ADRD). Although living alone is increasingly recognized as a risk factor for Alzheimer’s disease (AD) and
related dementias (ADRD),3 how living alone affects AD, particularly among African and Hispanic Americans
who are disproportionately affected by AD, remains poorly understood. Recent evidence indicates that
behavior and lifestyle interventions may prevent 30-40% of ADRD cases, improve cognitive and functional
symptoms of AD, and enhance quality of life (QoL). However, the uptake of these interventions remains low
in real life, due to failure in targeting Mechanisms of Behavior Change (MoBC). Moreover, older adults living
alone with cognitive decline, particularly those susceptible to health inequity, were often excluded by clinical
trials. Encouragingly, these issues could be addressed by technology, e.g., artificial intelligence and
wearable devices which older adults living alone with cognitive decline can feasibly access and use
technology. The strategic vision of the Arizona State University Roybal Center for Older Adults Living Alone
with Cognitive Decline (ASU Roybal) is to support MoBC-driven, technology-enabled intervention research to
address the needs of older adults living alone with cognitive decline by integrating the NIH’s Stage Model,
MoBC, Symptom Science Model, and NIA’s Health Disparities Research Framework. The goal of the
Administrative Core is to develop infrastructure, administer clinical trials, and evaluate and sustain ASU
Roybal’s long-term impact. The Administrative Core will be co-led by Ross Andel (lifestyle risk for ADRD)
and David W. Coon (Technology-enabled AD interventions). Andel and Coon have had extensive
administrative experience and will leverage rich expertise (e.g., gerontology, epidemiology, and technology)
within one of the most progressive institutions of higher education in the U.S. The specific aims are to 1)
establish the infrastructure to develop and advance clinical trials of MoBC-driven, technology-enabled
interventions for older adults living alone with cognitive decline; 2) champion the Center’s scientific activities,
including administering 12 trials of MoBC-driven, technology-enabled interventions in older adults living
alone with cognitive decline and coordinating data-sharing and enrichment programs; 3) develop the
evaluation metrics of success through formative and summative processes to continually evaluate and
improve the functioning of ASU Roybal; and 4) develop and carry out the sustainability plan to produce long-
term impact on preventing ADRD and improving QoL among older adults living alone with cognitive decline.
The Administrative Core is innovative in supporting the vision of ASU Roybal to develop scientists and
studies for older adults living alone with cognitive decline, critical recruitment resources, enrichment
activities, and a data repository for secondary data analyses with long-term impacts.